Cancer Center Support Grant

[unreadable] DESCRIPTION (provided by applicant): The University of California San Francisco Comprehensive Cancer Center is an NCI-designed matrix center conducting a wide range of inter-disciplinary research in the areas of laboratory, clinical and population sciences integrating the activities of 223 members working at 4 major campus and hospital locations. Its goals are to: (1) support cancer research of the highest possible quality, in the areas of laboratory, clinical and population sciences; (2) develop patient outreach and education programs to increase the value of the Center to the local community; (3) promote and develop first-class care for cancer patient in our affiliated hospitals; and (4) create an integrated community of investigators dedicated to the shared goal of translating innovative science into improved clinical care. These goals are accomplished through the following 11 Programs and 12 Shared Resources: [unreadable] [unreadable] Programs Shared Resources [unreadable] Breast Cancer Laboratory for Cell Analysis [unreadable] Neurologic Oncology Genome Analysis [unreadable] Cancer & Immunity Array [unreadable] Prostate Cancer Tissue [unreadable] Society, Diversity & Disparities Immunohistochemistry and Molecular Pathology [unreadable] Pancreas Cancer Transgenic/Targeted Mutagenesis [unreadable] Hematopoietic Malignancies Informatics [unreadable] Pediatric Malignancies Mouse Pathology [unreadable] Cell Cycling and Signaling Preclinical Therapeutics [unreadable] Cancer Genetics Mass Spectrometry [unreadable] Tobacco Control Biostatistics [unreadable] Clinical Research Support Services [unreadable]